INTERMITTENT INFUSION VS PATIENT-CONTROLLED ANALGESIA

To assess the usefulness of PCA as compared with intermittent IV infusion and to determine the best method of calculating dosages in pediatric patients suffering severe pain due to hematologic disorders.